GH12-008: Enhancing linkage to HIV care for newly detected HIV-positive persons in Ukraine

Project Summary Abstract Each year, more than 20,000 new HIV cases are registered in Ukraine, about 40% of them simultaneously with AIDS. Of the newly diagnosed HIV-positive individuals, only about 60% enroll in HIV care in the same calendar year. As a result, in the antiretroviral era, AIDS morbidity and mortality in Ukraine remain high and keep rising. While patients of specialized health care facilities (SHCFs) (substance abuse, TB, and STI clinics), where most patients with HIV risky behaviors are seen, have access to free HIV testing, there remains a critical need to improve engagement (linkage and retention) in appropriate HIV care for HIV-infected persons. A model of enhancing linkage to HIV care exists and proved to be effective over the U.S., but has not been tested in Ukrainian cultural context. The goal of this study is to pilot, implement and evaluate an intervention designed to motivate and manage recently HIV diagnosed patients of SHCFs in three regions of Ukraine, who will be supported and motivated to initiate and remain in HIV medical care. We will study the impact of the Modified Antiretroviral Treatment Access Study (MARTAS) intervention, based on the Social Cognitive Theory, motivational sessions and nurse case management, on the engagement in HIV care of recently detected HIV-positive patients. In our study we will use available health care infrastructure and human resources. This project will be implemented in Odesa, Dnipropetrovsk and Mykolaiv regions of Ukraine, at the SHCFs, where the system of patronage nurses exists, and provider-initiated HIV testing and counseling (PITC) approach has been implemented recently. The specific aims of the study are: 1) to adapt the ARTAS intervention protocol for implementation among recently diagnosed HIV positive patients in a Ukrainian cultural context using the results of formative assessment (in- depth interviews with patients and focus-group discussion with health care providers in Dnipropetrovsk); 2) to test the feasibility and acceptability of the intervention implementation at three sites of Mykolaiv region with 30 recently diagnosed HIV-positive patients; and 3) to evaluate the intervention effectiveness using prospective cohort study at 9 sites in three regions (n=300 recently HIV diagnosed patients) comparing the observed indicators of enrollment/retention in HIV care among study participants with the year prior to intervention implementation. We hypothesize that an intervention that involves coordination between specialized health care and HIV systems via a) linkage coordination delivered by a nurse of the SHCF, b) structured motivational sessions and further communication between these linkage coordinators (LCs) and patients, and c) communication between LC and HIV care provider will lead to increased engagement in HIV medical care. The proposed research addresses a significant public health threat of non-/late enrollment of HIV-positive individuals in HIV care and treatment. Our study is highly innovative, as we will extend the international borders of ARTAS implementation research to Ukraine, adapting it to the local infrastructure.

Public health relevance
Project Narrative Of the newly diagnosed HIV-positive individuals in Ukraine, only about 60% enroll in HIV care in the same year. In specialized health care facilities (substance abuse, TB, and STI clinics), where free HIV testing is available, there is a critical need to improve engagement (linkage and retention) in HIV care for HIV-infected patients. This study proposes to assess whether a modified Antiretroviral Treatment Access Study intervention, proved to be effective in the U.S. and based on the nurse case management approach, can impact the engagement in HIV care of recently detected HIV-positive patients in specialized health care clinics in three regions in Ukraine, using the existing local infrastructure. The proposed study addresses a significant public health issue of non-/late enrollment of HIV-positive persons in HIV care and treatment. __SpecificAimsTextDelimiter__ 1. SPECIFIC AIMS Overall: With the proposed project, we will tailor the proven effective case management intervention Antiretroviral Treatment Access Study (ARTAS) for the local context, and assess feasibility and effectiveness of the modified intervention in terms of engagement (linkage and retention) in HIV care among recently detected HIV-positive patients. This project will be implemented in Ukraine in the regions severely affected by HIV- Dnipropetrovsk, Odesa and Mykolaiv - at the specialized health care facilities (SHCFs) which provide care for patients with sexually transmitted infections (STIs), tuberculosis (TB) or substance abuse. The research will be conducted collaboratively by the Ukrainian Institute on Public Health Policy (UIPHP), local NGO Future without AIDS (FWA), with consultants from the U.S. University of California San Francisco (UCSF) and Brown University, and in consultation with the WHO country office, and with the support of the State Service of Ukraine on HIV/AIDS and Other Socially Dangerous Diseases which is the official regulatory body for SHCFs and AIDS Centers in Ukraine. This proposal is especially timely for Ukraine because, in year 2011, the provider- initiated HIV testing and counseling (PITC) approach was introduced in the SHCFs. These facilities where we aim to conduct the study, are home to a high proportion of most-at-risk- populations (MARPs). The proposal addresses key considerations of PEPFAR, including intensification of efforts to establish effective programs for engaging most affected populations in HIV prevention, care and treatment (1). This study will further enhance the research capabilities of Ukrainian investigators for future HIV prevention and treatment studies. Our efforts will improve upon the seek, test, treat, and retain paradigm (2) in Ukraine, specifically by implementing and evaluating an intervention designed to motivate and manage recently HIV diagnosed patients of SHCFs in three regions of Ukraine, who will be supported to initiate and remain in HIV medical care. The proposed implementation research team has a necessary capacity to conduct the proposed study. The project key personnel are professionals with expertise in HIV prevention research conducted in Ukraine and internationally, especially in the field of interventions to support engagement in HIV services. The implementation of the intervention will be facilitated with the clinical capacity of the participating SHCFs, including experienced staff, existing relationships with AIDS Centers and HIV service NGOs, and policies on confidentiality. We would like to work with CDC on implementation of proposed intervention per the options outlined in the RFA that discuss CDC and applicant roles and responsibilities. The specific aims of the study are as follows: 1. To adapt the ARTAS intervention protocol for implementation among recently diagnosed HIV positive patients in a Ukrainian cultural context using the results of formative assessment (in-depth interviews with patients and focus-group discussion with health care providers in Dnipropetrovsk). 2. To test the feasibility and acceptability of the intervention implementation at three sites of Mykolaiv region with 30 recently diagnosed HIV-positive patients. 3. To evaluate the intervention effectiveness using prospective cohort study at 9 sites in three regions (n=300 recently HIV diagnosed patients) comparing the observed indicators of enrollment/retention in HIV care among study participants with the year prior to intervention implementation.